Health and Biomedical Science for a Diverse Community, Phase II

DESCRIPTION (provided by applicant): Children's Hospital Oakland Research Institute (CHORI), in collaboration with the Hall of Health, a hands-on health museum, proposes a two year, Phase II SEPA project entitled Health and Biomedical Science for a Diverse Community. The purpose of this project is to disseminate (1) "Your Genes and Your Choices," a unique, interactive exhibit on social and genetic factors in health, and (2) a 4th and 5th grade health and biomedical science curriculum. The exhibit and curriculum were developed during Phase I. "Your Genes and Your Choices, "which has eight interactive stations and has been piloted at the Hall of Health, is designed for small science museums and health education centers. It will travel to four venues nationwide during Phase II and remain available to other venues after the grant ends. The innovative, activity based curriculum consists of eight instructional units that introduce students to scientific concepts and investigation in the context of the study of diseases and health conditions that disproportionately affect minority populations. The topics are: Fourth Grade: Unit 1: Nutrition: Balance and Imbalance (Obesity);Unit 2. Traumatic Brain Injuries;Unit 3. Infectious Diseases and Immunity;Unit 4. Environmental Toxics: Poisoning Prevention. Fifth Grade: Unit 1. Nutrition: Diabetes;Unit 2. Asthma and Lung Disease;Unit 3. Heart Disease;and Unit 4. Sickle Cell Anemia and Genetics. Each unit consists of five one hour lessons. The curriculum was piloted during Phase I, both in the classroom and in an after school science club, at two elementary schools serving predominantly minority children in Oakland, California. Now we propose to: (1) disseminate the curriculum via science clubs to ten elementary schools in Oakland and Berkeley;(2) offer a series of educator workshops to enhance the skills of teachers and after school personnel to teach scientific investigation and to incorporate the latest findings in biomedical science across the curriculum;and (3) hold family science festivals at each participating school to introduce parents to the topics of the science clubs. The festivals will include hands-on activities, talks by CHORI researchers, and focused discussions with healthcare providers on issues relating to minority health. This project involves clinical as well as basic science investigators, healthcare providers, teachers and health educators, high school and college students, and faculty from San Francisco State University and the University of California at Berkeley. The ultimate goals are to make science interesting and relevant to children who come from ethnically diverse, low income environments;to help them meet state and national objectives for learning in health, science, and scientific inquiry;to help them and their parents understand the relationship between science and health;and to foster their interest in science, so that they may consider future careers related to biomedical science. All project activities will be assessed through formative and summative evaluation. The science clubs will remain in place at the ten participating schools after Phase II funding ends, and the curriculum and evaluation tools will be posted on the internet, and thereby available to others.